Interrogating the ubiquitin pathway to understand and treat cytokine-induced beta-cell death in type 1 diabetes

PROJECT SUMMARY
The loss of insulin-producing beta cells in the pancreas results in an absolute requirement for injected insulin,
causing significant risks of mortality from hypoglycemia and morbidity from diabetic complications in peripheral
nerves, the retina, the heart, and the kidney. A key goal of efforts to treat T1D is to stop this cellular attack, either
by halting the immune mis-recognition of beta cells or by protecting beta cells from cell death. However, a critical
barrier to progress in the field is a lack of complete understanding of the cellular events in the islet that contribute
to the loss of beta-cell mass. Using a phenotypic screening approach, we discovered BRD0476, a compound
that is selectively active against cytokine-mediated apoptosis. Further study of this compound revealed that it
binds the deubiquitinase USP9X to halt JAK2 and STAT1 signaling in response to IFNγ. We determined that
JAK2 can be rendered signaling incompetent by ubiquitination, and that by modulating USP9X, we can tip the
balance toward reduced JAK2 kinase activity, even in the presence of IFNγ. These results point to an emerging
role for ubiquitination in regulating beta-cell apoptosis in T1D, and suggest that a greater understanding of this
process (and its potential dysregulation) in the early stages of T1D development could lead to 1) the ability to
identify at-risk individuals, and 2) novel therapeutic strategies to preserve beta-cell mass in early-stage T1D.
Using our probe BRD0476 and chemical biology tools not previously applied to islet biology, we will improve our
understanding of the role of USP9X in beta-cell survival in vitro and in vivo through the following aims: In Aim 1,
we will characterize the mode of JAK2 inhibition by USP9X in human islets. In Aim 2, we will assess effects of
inhibiting USP9X-JAK2 (with BRD0476) on development and progression of autoimmune diabetes in a mouse
model of type 1 diabetes. In Aim 3, we will profile deubiquitinase (DUB) expression and activity in human islets
during early T1D development, using activity-based protein profiling (ABPP) and global ubiquitome
measurements. The successful outcomes of this proposal are 1) a greater understanding of mechanisms to
promote beta-cell survival in early T1D, and 2) a chemical probe to provide translational proof-of-concept. This
project will set the stage for developing a biomarker of early-stage T1D development, as well as advanced
therapeutic strategies for preventing beta-cell apoptosis in early-stage T1D, representing a potentially curative
approach.

Public health relevance
PROJECT NARRATIVE We have uncovered an emerging role for protein ubiquitination in regulating beta-cell death in T1D. Here, we will use tools from chemical biology, cell biology, and mouse biology to develop a greater understanding of the complex signaling in the beta cell during T1D development and pursue an innovative therapeutic hypothesis for the treatment of T1D.